Therapies enabled by cardiovascular interventional MRI

During the past year we have continued our work applying rapid MRI to guide simple and complex mechanical and biological interventions. We have demonstrated successful real-time MRI-guided mechanical repair of aortic coarctation in a preclinical porcine model, and of aortic aneurysm in a simple porcine model. We also have applied real-time MRI to guide traversal of complex anatomic spaces, such as chronic total arterial occlusion in an animal model, and to guide traversal of non-anatomic spaces, such as atrial septostomy, in swine. Clinical studies are about to begin conducting human peripheral artery intervention wholly using real-time MRI. Clinical enrollment has begun in a human gene transfer experiment for therapeutic angiogenesis using a novel transcriptional upregulator; the trial will test safety as well as MRI assessment of efficacy.